NEPHROCALCINOSIS--A COMPLICATION OF BRONCHOPULMONARY DYSPLASIA

Assessment of the prevalence, etiology, natural history and long-term clinical significance of nephrocalcinosis in infants with bronchopulmonary dysplasia.